Repurposing Auranofin As a Novel Notch Pathway Inhibitor for Combinational Ovarian Cancer Therapy

Ovarian cancer is the deadliest gynecologic cancer, with ~20,000 new cases predicted for 2023.
Although first-line treatment with a platinum compound and taxane yields a response rate of more than 80% in
advanced ovarian cancer, the median time of progression-free survival is only 18 months. Retreatment can be
performed after relapse, but chemoresistance becomes a major issue. Therefore, new options for the treatment
of both primary and relapsed ovarian cancer are urgently needed. The Notch signaling pathway regulates cell
proliferation and differentiation. Aberrant Notch activation plays roles in the initiation, progression, and
chemoresistance of a variety of cancer types. Data from The Cancer Genome Atlas reveal that Notch-pathway
aberrations associate with 22% of high-grade serous ovarian cancer, and Notch pathway disruption can sensitize
ovarian tumor cells to platinum-based therapy. Accordingly, drugs that inhibit Notch signaling will be of great
value for treatment of Notch-associated ovarian cancers. To date, the utility of Notch-pathway inhibitors is limited
by dose-dependent and off-target toxicities. Most Notch inhibition strategies have focused on the level Notch
receptor activation. We hypothesized that modulating the interaction of RBPJ, the sole Notch transcriptional
effector, with its gene targets would provide a means to intervene in all Notch-associated cancers, regardless of
the mechanisms of aberrant pathway activation. We discovered that the FDA-approved drug auranofin is a potent
Notch pathway inhibitor. Moreover, we found that auranofin interacts synergistically with cisplatin, preferentially
reducing the viability of high Notch-expressing ovarian cancer cells. In this proposed study, we will use different
preclinical models to test the utility of
auranofin and cisplatin cotreatment for targeted ovarian cancer therapy.
We will use a collection of ovarian cancer cell lines to examine how levels of the different Notch receptors and
ligands impact the auranofin response. We will also use patient-derived tumor organoids (PDO) and patient-
derived xenograft (PDX) mouse models to examine auranofin and cisplatin synergy in 3-D culture and the
peritoneal environment.
We will also study how auranofin impacts cancer stem-cell expansion and cancer
relapse. The impact of these studies, if successful, will be significant, as our proposal has the potential to
repurpose an FDA-approved agent for immediate deployment in targeted therapy of both primary and relapsed
ovarian cancers that are Notch-dependent.

Public health relevance
Project Narrative Notch signaling pathway is a therapeutic target of great interest for cancer treatment. The values of current Notch inhibitors in cancer therapy remain to be proven. Therefore, our proposal to repurpose auranofin as a novel Notch pathway inhibitor for combinational ovarian cancer therapy is of great relevance to public health.